Evaluating the Use of Peer Specialists to Deliver Cognitive Behavioral Social Skills Training

Background: The Veterans Health Administration (VHA) is advocating that Veterans with serious mental ill-
ness (SMI) receive recovery-oriented, rehabilitation approaches that target real-world functioning. One such
approach is Cognitive-Behavioral Social Skills Training (CBSST). Unlike traditional cognitive-behavioral thera-
py, CBSST is a more recovery-oriented psychosocial rehabilitation intervention that teaches Veterans with SMI
to correct errors in thinking and build social skills. While effective, CBSST has only been tested when facilitated
by masters- or doctoral-level therapists, which limits its use in VHA. However, our pilot data shows that Peer
Specialists—individuals with SMI who are hired and trained to use their own recovery experience to assist oth-
ers with SMI—can also provide CBSST (called CBSST-Peer). Stand-alone social skills training (SST) is also a
recovery-oriented program that VHA is attempting to rollout nationwide for Veterans with SMI. A few Peer Spe-
cialists have been trained to co-lead SST with professionals. However, SST is not widely implemented be-
cause professionals are busy and Peer Specialist delivered SST has not been tested. This study will evaluate
the effectiveness of Peer Specialist-delivered CBSST and SST, which would increase access Veterans with
SMI have to effective treatment. Our aims are: Aim 1 (Effectiveness): To compare the impact of CBSST-Peer
on outcomes in Veterans with SMI to Veterans receiving Peer Specialist-delivered SST and Peer Specialist-led
manualized, goal-focused groups of equal duration. We will also assess fidelity of SST and CBSST. Aim 2:
(Helpfulness of CBSST/SST--Peer and implementation barriers and facilitators): To use focus groups
with patients and interviews with Peer Specialists and other staff to assess perceptions of SST- and CBSST-
Peer and identify potential barriers and facilitators to future implementation. Methods: This is a randomized,
Hybrid 1 trial involving 252 Veterans with SMI (n=126 each from Pittsburgh, San Diego) comparing 3 treatment
arms: CBSST-Peer vs. SST-Peer vs. a manualized, goal-focused group of equal duration. Hybrid 1 trials test
the effectiveness of an intervention and collect implementation data that could inform its future adoption. At
each site, across 6 waves (a wave = 1 CBSST-Peer, 1 SST-Peer, 1 goal focused group), 2 Peer Specialists
will co-lead 18, 20-week groups. Like in the pilot, Peer Specialists will be trained and receive an hour of super-
vision weekly by the CBSST developers. Master trainers from the SST rollout will train and supervise Peer
Specialists in each site. All three arms' sessions will be taped and 25% rated for fidelity on standardized
measures. A survey battery that assesses functioning, quality of life, recovery, and symptoms will be adminis-
tered to the Veterans in each wave at: baseline, mid-intervention (10 weeks), end-of-intervention (20 weeks),
and follow-up (32 weeks, 3 months post intervention). We will examine all outcomes using HLM, with treatment
condition included as a time-invariant covariate, and random intercepts for person and random slopes for time.
Relevant covariates will include site, treatment attendance, symptom severity, service use, and demographic
variables. We will evaluate the effect for treatment conditions (CBSST-Peer vs. SST-Peer vs. goal focused
group) in the expected direction and the time X group effect. Qualitative data on SST- and CBSST-Peer help-
fulness and implementation factors will be audio-recorded from a random sample of Veterans who participated
in SST- and CBSST-Peer (4 focus groups per site), participating Peer Specialists (interviews with n=6-8 per
site), and mental health administrators (interviews with about n=3-4 per site). Using a modified grounded theo-
ry approach, verbatim text will be coded to develop categories of responses regarding the helpfulness of, and
barriers and facilitators to, future implementation of SST- and CBSST-Peer in VHA. Innovation: No study has
tested peer-delivered SST or CBSST, or compared the two, in a rigorous trial. Significance/Expected Re-
sults: CBSST and SST are not widely available. If SST- or CBSST-Peer is effective, it could greatly increase
the delivery of evidence-based services Veterans receive and enhance the services by VHA Peer Specialists.

Public health relevance
This study examines two novel ways to improve functioning and recovery among Veterans with serious mental illness (SMI). It will assess the effectiveness of established psychosocial interventions based on cognitive- behavioral therapy (CBT) and stand-alone social skills training (SST) when delivered by Peer Specialists— Veterans with SMI trained to use their own experience and recovery to help other Veterans with SMI. The project will compare outcomes of Veterans with SMI receiving one of three treatments: Cognitive Behavioral Social Skills Training-Peer (CBSST-Peer), stand-alone Social Skills Training-Peer (SST-Peer), or a peer-led, manualized goal setting group. This work is responsive to national calls for Veterans with SMI to receive support that is evidence-based, improves functioning (not just symptoms), and is tailored to individual needs. If successful, CBSST or SST could be adopted by the 1100 Peer Specialists working in VA, greatly increasing the delivery of evidence-based services to these Veterans.